Project 2: Therapeutic Inhibition of Fibroblast Growth Factor and YAP Signaling in Cholangiocarcinoma: Preclinical Studies and Clinical Trial

PROJECT 2 – PROJECT SUMMARY
The overall objectives are to understand and define the cellular mechanisms that contribute to the
development and progression of biliary tract cancer, termed cholangiocarcinoma (CCA). Advances in CCA
therapy will require an understanding of molecular signaling pathways, and validation of targeted agents
coupled with biomarkers for patient selection. Both the Hippo and fibroblast growth factor receptor 2 (FGFR2)
signaling pathways have been implicated as oncogenic mediators in CCA. In this application, we unify these
observations by positing cross-talk between the Hippo and FGFR2 signaling pathways in CCA. Consistent with
this concept, we have generated preliminary data demonstrating that Hippo signaling via activation of the
transcriptional co-activator YES-associated protein (YAP) drives expression of FGFR2, and in turn FGFR2
signaling mediates YAP activation. Further evaluation of the pathway demonstrates tyrosine phosphorylation of
YAP that appears to be dependent on Src family kinases (SFKs). Tyrosine-phosphorylated YAP in turn
associates with TBX5, driving oncogenic transcriptional activity. From a pre-clinical therapeutic perspective,
inhibition of FGFR2 signaling induces tumor cell death in patient derived xenografts with YAP nuclear
immunoreactivity but not in those negative for this marker of Hippo pathway signaling. Based on these
preliminary data, we propose the central hypothesis that CCA progression can be driven by FGFR2-mediated
YAP tyrosine phosphorylation by SFKs. We will now employ current and complementary molecular,
biochemical, and cell biological approaches, and preclinical CCA models to examine this hypothesis. Our
specific aims will test three hypotheses. First, that YAP drives specific FGFR2 expression, which in turn
promotes YAP signaling by: (a) FGFR-mediated SFK activation and YAP tyrosine phosphorylation; and
(b) Tyrosine-phosphorylated YAP co-activated by the TBX5-mediated transcriptional expression of FGFR
family members. Second, by that YAP nuclear localization serves as a biomarker for response to FGFR2-
targeted therapy: (a) In unselected patient-derived xenografts (PDX) treated with an FGFR inhibitor; and (b) In
conjunction with evidence for a YAP activation signature in PDX. Finally, that inhibition of FGFR signaling is
therapeutic in patients with CCA: (a) In FGFR2 fusion negative / YAP nuclear positive CCA patients receiving
INCB054828, a panFGFR inhibitor, in the setting of a clinical trial; and (b) By interruption of Hippo signaling
pathways. The proposal, which is technically and conceptually innovative, is also highly significant because it
identifies new mechanisms for CCA oncogenic signaling and will help identify therapeutic strategies for the
treatment of CCA, namely FGFR inhibition coupled with a biomarker (i.e., nuclear YAP localization) for patient
selection.

Public health relevance
PROJECT 2 – PROJECT NARRATIVE This application examines the cellular mechanisms by which cancer of the bile ducts, termed cholangiocarcinoma, develops and progresses. We propose that cross-talk between intracellular signaling pathways within individual cancer cells transmits potent cellular signals, resulting in cancer progression. We will ascertain whether disruption of these signals results in tumor cell death and therapeutic cancer regression in preclinical models and in a proof-of-concept clinical trial. By developing and validating biomarkers, we anticipate identifying which patients are most likely to benefit from the targeted therapy under study. The results of these studies have the potential to provide greater understanding of human bile duct cancer biology and identify new therapeutic strategies coupled with biomarkers for the treatment of this cancer.